Integrative Analysis of Adaptive Information Processing and Learning-Dependent Circuit Reorganization in the Auditory System

Abstract
Decades of research have revealed the principles of information processing that give rise to auditory spatial
tuning and experience-dependent adaptive plasticity in the owl auditory system. This is a strong foundation
on which to build a multiscale understanding of circuit function from synapse to behavior. Towards these
goals, this project will investigate: (a) the rules of synaptic integration of binaural cues and sound frequency
using a newly developed patch-clamp preparation in combination with volume electron microscopy to
reconstruct the connectivity motifs underlying these computations; (b) population decoding schemes using
multielectrode arrays to further test our field-leading model that orienting to auditory targets is implemented
by readout of an entire neural population, approximating statistical inference, and (c) the microanatomical and
population-level mechanisms of behavioral learning using two complementary plasticity paradigms, prism
adaptation and ruff cutting. Achievement of these goals, implemented by a multiple-PI group with a
complementary expertise set, will establish for the first time links between synaptic and cellular network
architecture underlying single neuron computation, population responses and experience-dependent coding
of statistically adaptive and experience-dependent sound localization behavior. At each level, the questions
pursued in this integrative project are framed in terms of common mechanisms and hypotheses expected to
be shared broadly across circuits and species.

Public health relevance
Narrative The proposed research seeks to elucidate cellular and synaptic mechanisms, network architecture, and neural code commanding a natural statistically driven behavior and how these properties change and implement adaptive learning. This goal will be pursued in the midbrain sound localization system of the owl. Owls’ specialized sound localizing ability and behavior offers advantages for connecting behavior with the underlying neural representation of natural statistics of sensory cues. This project’s approach is multidisciplinary, combining novel ex vivo and in vivo population recordings in anesthetized and non-anesthetized animals, experience-dependent paradigms, volume electron microscopy, behavioral tests, and theoretical neural models. If successful, this novel work would provide a thorough explanation of a sound-driven behavior from the activity of complete neural populations down to the network connectivity supporting it, and how experience affects functional and anatomical circuit properties inducing statistically adaptive learned behaviors. If successful, this project could significantly expand our understanding of common principles of information processing and learning that operate across circuits and species.